The Social-Medical Network: Using a Network Approach to Explore the Integration of Informal and Formal Care Networks of Older Adults

PROJECT SUMMARY
Due to factors such as multimorbidity and access to Medicare health insurance, older adults are often frequent
users of the formal health care system. Their formal health providers may range from primary care providers to
specialists (e.g., cardiologist) and direct care workers. The various formal health care providers of an older
adult form a social network of care. Thus, the connections that exist between the older adult and their formal
health care professionals act as a formal care network, centered on the older adult. In addition to formal health
care providers, older adults may have informal caregivers, defined as family, friends, and neighbors who
provide care to older adults or individuals with disability, illness, or other debilitating conditions. There is a lack
of research about the number of informal caregivers, the type and amount of care and support provided, and
the quality of the relationship between the patient and caregiver. There is also a gap in examining how informal
caregivers of an older adult form a social network of care, or an informal care network centered on an older
adult. Literature has suggested that these two networks (i.e., formal and informal) do not operate
separately but instead are dynamically integrated. The interaction between the two networks forms a
larger network: The social-medical network. The social-medical network represents the larger network
comprised of the two subnetworks and their integration (density) across. To our knowledge, no studies
have proposed nor been conducted on the social-medical network. There is also little understanding on how
the informal and formal care networks operate together to improve health outcomes for older adults. Using
social network methods and analysis, this study aims to measure the social-medical networks of older
adults and explore its association with escalating acute service utilization (e.g., urgent care,
emergency department, and unplanned hospitalization). This study will examine the social-medical
network among a population of older adults with Type 2 diabetes. The specific aims of this study are (SA1) To
characterize the structure, function, and quality of the informal care, formal care, and social-medical networks;
(SA2) To compare escalating acute service utilization by the characteristics of the informal and formal care
subnetworks; and (SA3) To examine the association between density of the social-medical network and
escalated use of acute health services. This study will measure an unexplored network that may be associated
with utilization outcomes of older adults, laying the foundation for improving the human healthspan, improving
lives of informal caregivers, lowering health care costs, and strengthening care communities. This research
also aligns with the NIA’s mission and research strategies to promote innovative work in areas and disease
domains with established health disparities among older adults, such as Type 2 diabetes. Findings will
contribute a new concept to the literature, a novel application of existing methods, and additional mechanisms
that may influence the health outcomes of an older adult.

Public health relevance
PROJECT NARRATIVE While health care professionals provide medical care and treatment for a patient, other individuals (e.g., friends, family, neighbors) provide informal care and support. These two care networks form a larger network, the proposed social-medical network. Exploring the relationship between an older adult’s social-medical network and their acute service utilization, such as urgent care, emergency department, or unplanned hospitalization, may illuminate opportunities for intervention within the health care system and community to prevent avoidable acute service utilization for and promote well-being of older adults.